Administrative Core

The Administrative Core (AC) will critically contribute to the success of this drug development project,
“Developing small molecules to engage an analgesic GPCR in pain unpleasantness neural circuits.” Given the
interdisciplinary scope and complexity of this project, a robust support infrastructure will be essential to facilitate
effective collaboration throughout the project. The AC is directed by Dr. Grégory Scherrer (Lead), with the
assistance of Drs. Mark Schnitzer and Jeff Aubé (Co-leads), Dr. Alex Abuin (Collaborator), Program Manager
Josh Blair, and support staff. These personnel have ample experience in the scientific direction and
administrative management of large collaborative projects, as well as an extremely high degree of expertise in
their respective fields of study. This AC leadership team therefore possesses all the experience and expertise
necessary to support the establishment and successful execution of this multidisciplinary research program. Dr.
Scherrer, Dr. Schnitzer, and Program Manager Blair will each actively contribute to both the AC and Data
Management Core (DMC), thereby ensuring fluid communication and effective coordination between the two
U19 support cores. Moreover, Drs. Scherrer, Schnitzer, and Aubé will all lead and/or co-lead one or more
Research Components (RCs), ensuring a highly collaborative environment throughout the project period.
Together, this AC team will: provide organizational structure, administrative support, and DMC coordination (Aim
1); maintain frequent and productive communication to promote effective collaboration (Aim 2); integrate,
evaluate, and report overall research progress (Aim 3); and foster highly inclusive and uniquely multidisciplinary
training, mentorship, and collaboration opportunities (Aim 4) that will strengthen all research teams involved in
this project, as well as the scientific community as a whole.